Administration Core

PROJECT SUMMARY (ADMINISTRATION)
The National Center for Biomedical Imaging and Bioengineering delivering “Technology to realize the full
potential of UHF MRI” has an Administrative Core that coordinates all NCBIB related activities, including the
development of ultrahigh field (UHF) magnetic resonance (MR) and optical imaging/MR technologies, their
dissemination, and training of researchers in their use. The co-PIs of this core are Drs. Kamil Ugurbil and Greg
Metzger. Dr. Ugurbil is an expert in UHF MR methodology and instrumentation with longstanding experience
managing multi-center collaborations. Dr. Metzger is an expert in UHF MR technology and its application with
experience developing and managing interdisciplinary research programs. Daily operations of the NCBIB are
the responsibility of the Co-PIs in close interaction with the Technology Research and Development (TRD)
project leads. The full leadership group of the NCBIB together with key Center faculty and staff managing
resources at the Center for Magnetic Resonance Research (CMRR), comprises the Operations Committee,
which meets biweekly. The main goal of this committee is to assure that access to and use of the NCBIB
resources is accomplished in a fair and transparent manner including ensuring the push-pull relationship with
the Collaborative Projects and a path for access to the technology developments for the Service Projects. The
task of the Operations Committee is facilitated by operating procedures and tools which help manage requests
and prioritize projects, including both 1) a web-based interface for requesting access to Center resources and 2)
faculty and staff support to guide users in the process. Additional infrastructure in the Center is available to
ensure projects can be carried out in a safe and successful manner including the following: Pre-IRB Review
System, Incidental Findings Review System, 3T Operations Committee, Safety Committee and Magnet Operator
Training. The progress of the NCBIB is reviewed yearly by the External Advisory Committee (EAC) comprised
of experts in the fields of our TRDs. The primary role of the EAC will be to annually review our scientific progress
and our progress in collaboration, service, training, and dissemination goals. The results from the meeting will
be incorporated into a yearly report drafted by the EAC, which will be submitted to NIBIB as part of the annual
progress report. Through the activities of the administrative core and the consistent and substantive institutional
support from the University of Minnesota, our long-term goal is the establishment of a national biotechnology
research resource for the development of unique technologies that advance biomedical research and discovery.